Role of glycans in VWF biology and VWD pathogenesis

PROJECT SUMMARY: PROJECT 4
Partial quantitative deficiency of VWF accounts for approximately 70% of all cases of VWD. Previous
studies have demonstrated that reduced plasma VWF levels (particularly mild to moderate reductions in the
30-50 IU/dL range) are commonly independent of the VWF gene on chromosome 12. Importantly, GWAS
studies have also highlighted significant associations between plasma VWF-FVIII levels and a number of
glyco-related genes. Critically however, although complex N- and O-linked carbohydrate determinants have
been shown to influence multiple aspects of VWF biology (including biosynthesis, activation, proteolysis and
clearance), the mechanisms through which specific glycans modulate these effects and contribute to VWD
pathogenesis remain poorly understood. This project will investigate the role of VWF glycans in regulating
VWF biology using a series of parallel strategies underpinned by unique clinical and genomic resources
assembled through the previous Zimmerman PPG. Aim 1 will investigate the mechanisms through which N-
and O-glycans regulate VWF biosynthesis and/or secretory pathways. Importantly, our preliminary studies
suggest that alterations in both N-linked and O-linked glycans differentially modulate VWF biosynthesis within
EC. In collaboration with clinical and genomic cores, we will specifically address the hypothesis that
abnormalities in VWF glycosylation machinery play causal roles in VWD pathogenesis. In Aim 2, we will
characterize the roles of glycans in regulating VWF activation and its functional properties. In particular, we
will investigate the concept that O-glycans flanking the A1 domain within the recently described autoinhibitory
module (AIM) region play important roles in regulating VWF activation and thereby influence functional
activity and clearance. Finally, Aim 3 will focus on defining the mechanisms through which VWF glycosylation
and activation influence its clearance through specific lectin and scavenger receptors. In addition, the
importance of aberrant VWF glycosylation in the pathogenesis of VWD will also be investigated.